Antibiotics, Juvenile Idiopathic Arthritis, and Antirheumatic Treatment Response

Antibiotics are overprescribed in pediatric populations, and antibiotic-exposed children can have signs of
gut microbiota imbalance (dysbiosis) for months to years afterwards. Gut microbiota play key roles in
immune development and function. Correspondingly, dysbiosis and early childhood antibiotic exposure
have been implicated as potential causes of juvenile idiopathic arthritis (JIA). Studies on antibiotics and
JIA have been restricted to two European populations of mostly young children, and their findings need
replication and deeper examination in broader, more diverse populations. The use of conventional and
biologic disease-modifying antirheumatic drugs (DMARDs) has vastly improved outcomes for children
with JIA, but response to specific drugs is variable and difficult to predict. Methotrexate (MTX), the most
common DMARD used to treat JIA, is toxic to certain commensal bacteria found in higher abundance in
children with JIA. Moreover, early evidence suggests that certain gut microbiota can metabolize MTX,
and adults with rheumatoid arthritis who respond poorly to MTX may have different gut microbiota from
responders. There is a critical need to understand better how a potentially modifiable factor—antibiotic
exposure—affects variability in JIA incidence, phenotype, and therapeutic response to DMARDs such as
MTX so that children receive appropriate, effective medicines. This project's long-term goal is to ensure
that all children with JIA receive effective and safe treatment and to identify new modalities for JIA
treatment and prevention. The overall objective of this proposal is to understand how antibiotics affect
the risk of developing JIA and the response to standard JIA treatments. This project will (1) test how
patterns of antibiotic exposure relate to incident JIA and JIA phenotype and (2) determine whether recent
antibiotic exposure in children with JIA starting DMARDs is associated with early changes in therapy.
The central hypothesis is that antibiotic exposure increases the risk of JIA and impairs the therapeutic
response to MTX more than to other DMARDs, such as tumor necrosis factor inhibitors. The project team
will use administrative claims data to conduct retrospective cohort studies on the effects of antibiotic
exposure in large, diverse general pediatric populations (Aim 1) and in patients with JIA starting MTX and
other DMARDs (Aim 2). The proposed research will yield novel and important information about the
potential risks of antibiotics in relation to the most common pediatric rheumatic disease and standard
antirheumatic drugs. This research will produce critical clues about underlying mechanism for potentially
differential responses to specific DMARDs. Furthermore, this project will lay important foundations for
future interventions to limit infections and inappropriate antibiotic use in children and potentially to
manipulate microbiota in order to treat or prevent JIA and promote DMARD effectiveness and safety.

Public health relevance
The proposed study will investigate whether antibiotics could contribute to the development of juvenile idiopathic arthritis and impair the ability of children with juvenile idiopathic arthritis to respond to standard treatments, such as methotrexate. This research could support novel efforts to curb antibiotic overuse in children and to alter gut bacteria (for example, through diet or probiotics) as a way to prevent juvenile idiopathic arthritis and promote the use of effective, tailored, and appropriate medicines.